Leverage Points for Equitable Systemic Change to Reduce Alcohol Exposed Pregnancy

Continued trends of alcohol exposed pregnancy (AEP) indicate a great need for higher quality AEP-reduction programs, particularly those that address AEP health disparities within at-risk populations and communities, such as American Indian (AI) women. These programs do not account for the broad constellation of factors pertinent to AEP, in particular, the role of intimate partner violence (IPV), which forms a syndemic association with two other AEP indicators (alcohol use and unplanned pregnancy). System dynamics methods are effective strategies for understanding of how AEP and this syndemic are nested within a broader system of interpersonal, intrapersonal, and institutional factors. This method is especially beneficial for addressing the current AEPrelated health disparities within AI communities, especially when adding how equity and inequity can impact the system. Community-based system dynamic models allow practitioners and policymakers to determine the best system areas for implementing policies and programs that will produce the biggest changes in AEP. The current proposal uses community-based approaches to develop equity-informed AEP system models for AI women within a small metro area in western South Dakota. The goals of this project are to build qualitative and quantitative system dynamic models that that represent the AEP system in partnership with our highly collaborative community-researcher team. We will parametrize and validate these models utilizing a variety of community data sources. The proposed research is significant as it accounts for the often-ignored underlying matrix of contributors which maintain community levels of AEP and AEP health disparities. This project serves as a valuable extension of the PI’s current COBRE grant, and provides her with a strong foundation for utilizing this research in future grants as an independent researcher. This project is innovative due to the integration of system simulation and community-based approaches to address complexity, of this issue, and the deliberate attention to health inequity as a contributor to disparity. The close working partnership between researchers and the communities of interest are together a powerful collaborative to facilitate project success and meaningful contributions to community health. Findings from this study provide critical information about the broad system underlying AEP and AEP health disparities, as well as a clear mechanism for developing a strategic blueprint for systematic change within AI communities.

Public health relevance
There is a great need for higher quality alcohol and substance exposed pregnancy (ASEP) reduction programs that account for the constellation of interpersonal, intrapersonal, and community-level contributors. Such programs are particularly important for addressing ASEP-related health disparities within at-risk communities, such as American Indian (AI) women. This proposal utilizes community-based system dynamics simulated models to test and discern high-impact areas for intervention and best strategies for translating these findings into action-based systematic change.